RNA binding and packaging by retroviral Gag proteins

Summary
HIV-1 packages two copies of unspliced viral RNA as a dimer into newly budding virions. The unspliced viral
RNA also serves as an mRNA template for translation of viral proteins. Recent studies showed that the fate of
the viral RNA (genome vs. mRNA) is determined at the level of transcription. Host RNA polymerase II uses
heterogeneous transcription start sites (TSSs) to generate major transcripts that differ in only two guanosines at
the 5ʹ end (referred to here as 1G and 3G RNA). Remarkably, this two-nucleotide (nt) difference is sufficient to
alter the structure of the 5ʹ-untranslated region (UTR) and generate two pools of RNA with distinct functions; 1G
RNA is selectively packaged by the viral Gag protein and functions as the genome, whereas 3G RNA is
preferentially translated by the ribosome. The presence of both RNA species is needed for optimal viral
replication and fitness, but gaps remain in our understanding of the mechanism by which different RNA structures
dictate viral and host factor interactions and thereby impact function. Our long-term goal is to understand how
TSS choice influences HIV-1 RNA interactions and function. We previously showed that the stability of the
“polyA” hairpin in the 5′UTR is a key regulator of the conformational equilibria, resulting in exposed (1G) versus
sequestered (3G) dimerization and Gag binding sites. Tuning polyA hairpin stability allowed us to alter the
conformational landscape and packaging selectivity. HIV variants that only express 1G or 3G major transcripts
are in hand and will serve as key tools that will enable us to address exciting open questions. The proposed
aims will test our major hypothesis that the different RNA structures formed due to TSS heterogeneity
significantly impact viral and host factor interactions, RNA 5ʹ-modification, and ribosome loading and scanning.
We will: (1) identify and characterize the HIV-1 1G and 3G interactomes in vitro and in cells; (2) determine how
HIV-1 TSS choice affects RNA 5ʹ-end modification and dynamics; and (3) determine how HIV-1 TSS choice
affects translation in vitro and in cells. The results will help guide the design of novel therapeutic agents that
target the 5′UTR and interfere with its essential conformational plasticity.

Public health relevance
Narrative The HIV-1 genome is made up of approximately 9,200 RNA nucleotides and serves not only as genomic material that must be specifically packaged into new viral particles, but as an mRNA template for synthesis of viral proteins. How a tiny 2-nucleotide difference in the viral RNA species generated dictates their fate as genome versus mRNA is the focus of this work. The results of the studies proposed herein will help guide the design of antiretroviral therapeutics targeting the mechanisms that determine viral RNA fate.